Cellular and circuit investigation of age-dependent social behaviors

PROJECT SUMMARY
Understanding the neural basis of social behavior across development is critical, especially given its implications
for a plethora of mental health conditions that result from severe disruptions in social relationships from infancy.
Our preliminary studies suggest POMC neurons in the hypothalamus—the brain's source of the potent
endogenous opioid, beta-endorphin—might be key players in social behavior during development. For instance,
social interactions rapidly activate these neurons in juvenile mice (P24-30) and optogenetic activation of POMC
neurons causes strong place preference, suggesting these neurons at this age have rewarding properties. These
results—combined with the known molecular heterogeneity and developmental changes in POMC neurons—
leads us to hypothesize that POMC neurons are differentially attuned to social behaviors during development to
increase social reward; when social behaviors are heightened, as for example during the juvenile period, POMC
neurons are recruited, modulating the response to social interactions. On this R21, our overarching goal is to
elucidate how POMC neurons respond to social stimuli and regulate social behaviors during development with
cellular and circuit resolution. In Aim 1, we will map the in vivo responses of POMC neurons to social cues with
unparalleled single cell precision, leveraging novel procedures that our group has developed to perform in vivo
two-photon microendoscopy in awake infant (P16-18), juvenile (P24-30) and adult (P65-80) mice. In Aim 2, first,
we will record the activity of the POMC neuron projections in the nucleus accumbens to determine the dynamics
of circuit-specific POMC neuron activity in relation to social interactions in infant, juvenile, and adult mice.
Second, we will explore the effects of inhibiting the same projections on social learning. Overall, by elucidating
how POMC neurons respond to social interactions and and influence social behaviors during a formative period
of brain development, this research will provide foundational knowledge on how the developing brain regulates
age-specific social behaviors. The findings from this research could pave the way for novel approaches to
mitigate mental health conditions that stem from disruptions in social behaviors in early life. Moreover, the
methodologies developed through this work promise to offer valuable tools for the broader neuroscientific
community, enabling investigations into neurodevelopmental processes that play a role in physiological and
behavioral processes with cellular and circuit resolution.

Public health relevance
PROJECT NARRATIVE Despite the importance of healthy social development, we have little understanding of how neural mechanisms for social motivation change from infancy to adulthood. This research aims to shed light on how hypothalamic POMC neurons, which are the producers of the endogenous opioid beta-endorphin in the brain, coordinate social motivation from infancy to adulthood. Ultimately, understanding the neural basis for social development has implications for a plethora of mental health conditions rooted in early life disruptions in social relationships.